Does vestibular loss predict falls in patients with Alzheimer's Disease?

Project summary
This project investigates whether vestibular loss predicts falls in patients with Alzheimer’s disease (AD).
The proposed research is an observational study of 150 patients with AD to evaluate the association
between baseline vestibular function and 2-year incidence of falls. We will also explore whether vestibular
function is associated with balance and gait function, as well as spatial cognitive function, as potential
mechanisms by which vestibular function contributes to fall risk. Specifically, Aim 1 is to determine
whether vestibular loss predicts falls in patients with mild-moderate AD. We hypothesize that poorer
vestibular function at baseline predicts a higher 2-year incidence of falls. Additionally, we hypothesize that
the attributable risk of falls associated with vestibular loss will be substantial enough (>~10%) to warrant
further investigation of vestibular therapy as a clinically significant modifier of fall risk. Aim 2 is to evaluate
whether vestibular loss in AD predicts impaired static and dynamic balance, measured using the Berg
Balance Scale (BBS) and the Timed-Up-and-Go (TUG) test. We hypothesize that greater reduction in
vestibular function over the 2-year follow-up period predicts greater decline in BBS and TUG performance.
Aim 3 is to evaluate whether vestibular loss in AD predicts impaired spatial cognitive skills. We will
administer cognitive tests of spatial cognition (including the Money Road Map test, the Card Rotations
test, the Visual Form Discrimination test and the Clock Drawing test), and we will also query participants
and caregivers about difficulty with driving, losing objects, getting lost and wandering behaviors as
functional manifestations of impaired spatial cognition in AD patients. We hypothesize that greater
reduction in vestibular function over the 2-year follow-up period predicts greater decline in spatial cognitive
test scores, and a higher incidence of functional spatial cognitive impairment. Moreover, we hypothesize
that impaired balance measures (from Aim 2) and impaired spatial cognitive skills will both be independent
mediators of the association between vestibular loss and incident falls. To accomplish these aims, we will
leverage well-established resources at Johns Hopkins including the Johns Hopkins Alzheimer’s Disease
Research Center and the Memory and Alzheimer’s Treatment Center. Falls are a major source of
morbidity in AD and current interventions are not uniformly effective. If our observational studies
demonstrate that vestibular loss is associated with poorer balance and spatial cognition and incident falls,
these results will inform the design of interventional trials to prevent falls in AD patients.

Public health relevance
Project narrative Nearly 2 out of 3 patients with Alzheimer’s disease (AD) experience a fall, and efforts to reduce falls in patients with AD have not been uniformly effective. The vestibular (inner ear balance) system is a known contributor to falls risk in cognitively-intact older adults; however, whether vestibular loss is associated with falls in AD has never been investigated. In this study, we will investigate whether vestibular loss predicts falls in patients with AD, and to explore whether vestibular loss contributes more broadly to a “spatially-impaired” subtype of AD.